NATIONAL MEDICAL SERVICES:1106803 [25-002907]

The specific aims of the NeuroBioBank Tissue Toxicology Testing Services are to: 1) provide toxicology screening to detect the presence and abundance of drugs of abuse, therapeutic drugs, and environmental toxins in human postmortem samples, including brain, and blood; 2) return quantitative results of all toxicological tests to the submitting Neurobiobank brain bank and to the NIH COR or to the COR’s designee; and 3) maintain a secure, cumulative database of toxicology test results